INTRAPARTUM PHARMACOKINETICS OF MEPERIDINE

The purpose of this protocol is to test the hypothesis that the route of administration (I.M. or I.V>) would affect the amount of meperidine and normeperidine reaching the fetus, and thus affect neonatal neurobehavioral indices.